Statistical Machine Learning to Develop Connectome-Based Biomarkers of Alzheimer's Disease and Related Dementias

Project Summary
Alzheimer’s disease (AD) is a prevalent chronic neurodegenerative disorder, projected to affect between 11 to 16
million individuals in the US by 2050. Neurodegeneration in AD initiates with the formation of amyloid beta
(A) plaques decades before observable symptoms. This latent, pre-clinical phase represents a crucial "window
of opportunity" when new A lowering therapies can slow the disease progression and mitigate its clinical
impacts. However, existing biomarkers of preclinical AD, such as cerebrospinal fluid (CSF), plasma and positron-
emission tomography (PET), face significant limitations. This underscores an urgent need for readily available and
noninvasive biomarkers capable of detecting AD at its latent, preclinical, stage when disease-modifying therapies
are most effective. Resting state functional MRI (rs-fMRI) is gaining recognition for its potential to provide non-
invasive biomarkers for AD pathology, particularly through the assessment of alterations in functional connectivity
(FC) dynamics and networks related to A deposition. However, current computational approaches for analyzing
rs-FC networks and their dynamics have notable limitations, including the use of ad-hoc or black-box analytical
methods, over looking heterogeneity in rs-fMRI data and dynamic FC across subjects and populations, and limited
sample sizes, impacting the applicability, generalizability, and replicability of existing biomarkers and their ability
to reveal underlying disease mechanisms. This project aims to rectify the deficiencies in current computational
methods and is grounded in the fundamental hypothesis that improved biomarkers for early detection of AD
and related dementias (ADRD) can be obtained by leveraging the dynamics of rs-fMRI data and FC, while
accounting for heterogeneity across subjects and studies. To achieve this goal, the first aim develops a new model
to comprehensively capture the dynamics of FC and offer robust biomarkers for AD pathology by assessing the
accumulation of 𝐴. To account for individual level heterogeneity, the second aim develops a multivariate dynamic
models featuring both local and global structures to incorporate heterogeneous brain connectivity among different
brain states in different individuals. The third aim then develops effective techniques for detecting alterations
in brain connectivity networks, while accounting for subject-level heterogeneity through random effects, helping
uncover underlying processes of ADRD initiation and progression. Finally, to address the limited sample sizes in
individual studies, the fourth aim proposes an innovative transfer learning framework that leverages the inherent
similarities among multiple datasets to improve the reliability of connectome-based ADRD biomarkers. Upon
evaluation and validation, the above methods will be implemented as efficient, open-source software tools in
form of R-packages and python libraries, accompanied with extensive documentations, illustrative examples,
and interactive visualization capabilities, to maximize the adoption of the proposed methods by the broader
community.

Public health relevance
Project Narrative Alzheimer’s disease (AD) is a prevalent chronic neurodegenerative disorder that currently stands as the most rapidly growing cause of death in the United States and is projected to impact between 11 and 16 million Americans by 2050. Successful completion of the current study will furnish non-invasive connectome-based biomarkers of AD and related dementias (ADRD) that would enhance our understanding of the disease’s initiation and progression, and would facilitate a more precise diagnosis of ADRD before clinical symptoms manifest. Utilizing these biomarkers would facilitate effective implementation of amyloid beta lowering treatments in the early stages of the disease, presenting the best chance for successful intervention.